Core 1

Core 1 is the conceptual driver for the entire Center. It is founded on the conviction that the physical sciences in general, and physics in particular, offer new and penetrating insights into the origin, behavior and management of cancer. By asking disruptive, provocative and challenging questions, the Core will facilitate the sort of major conceptual leap that will transform understanding ofthe subject. Core 1 will exploit the highly successful brainstorming ethos ofthe Beyond Center for Fundamental Concepts in Science at Arizona State University, a think< tank dedicated to grappling with the deepest foundational questions ranging across the sciences. It will be responsible for the overall scientific mission, and will take responsibility for the convergence, integration and interpretation ofthe three experimental projects. A key component of Core 1 is the Cancer Forum, the main part of which is a workshop program that will critically examine challenging new hypotheses, and transform them into implementable research projects. The workshops will focus on conceptual issues surrounding the physical correlates of cancer, including its origin, evolution, diversification and progression, viewed as physical processes. They will capitalize on the creative synergy of bringing biologists and physical scientists together to think outside the box and examine the hidden assumptions that underlie existing research themes. Consideration will be given equally to experimental, clinical, theoretical and mathematical modeling aspects ofthe subject. The goal will always be to ask, Are we thinking about this the wrong way?

Public health relevance
Progress in cancer has been incremental, but slow. Our Center seeks to create a new paradigm based on the physical correlates of cancer cell progression. Its education and outreach components, to be managed by Core 1, targets sections ofthe community with special vulnerabilities to cancer, as well as training a new cadre of scientists working at the interface of physics and cancer cell biology.